Neurocognitive Outcomes and the Trajectory of Recovery One-year After Pediatric Sepsis

PROJECT SUMMARY
Acute brain dysfunction (ABD) during sepsis occurs in 30% of children and is associated with a seven-fold
increased risk of mortality. Survivors who experienced ABD during sepsis are more likely to have both
functional morbidity and a reduction in health-related quality of life. However, there is a critical knowledge gap
about the prevalence of new neurocognitive morbidities for sepsis survivors. With 100,000 children in the
United States and 25 million children worldwide experiencing sepsis each year, new neurocognitive morbidities
can have a lasting impact on their development. Our overarching goal is to identify the prevalence of new
neurocognitive morbidities up to 12 months after hospital discharge and to determine if acute brain dysfunction
during sepsis is a modifiable risk factor that can be targeted to improve these outcomes. This K23 proposal
leverages the robust research infrastructure and resources at the Children’s Hospital of Philadelphia (CHOP)
and the University of Pennsylvania (UPENN). We propose a prospective longitudinal study of 180 school-aged
sepsis survivors to evaluate the prevalence of new neurocognitive morbidity at 3 months after discharge,
including the association of ABD during sepsis with new morbidity (Aim 1), the trajectory of neurocognitive
recovery through 12 months for children with and without ABD during sepsis (Aim 2), and the association of
high anticholinergic exposures during sepsis to ABD during sepsis (Aim 3). Neurocognitive status will be
assessed at 1-, 3-, 6- and 12-months following discharge using two validated, caregiver-reported measures:
PedsQL Cognitive Functioning Scale and the Behavior Rating Inventory of Executive Function. Additionally, in
Aim 2, a subset of children will return for formal in-person, performance-based neuropsychological evaluation
at 12 months to characterize neurocognitive function compared to age-matched normative data. In Aim 3, we
will test the association between anticholinergic exposure with ABD during sepsis in the CHOP Sepsis Registry
(6,500 patients) using a validated score to quantity the cumulative anticholinergic exposure. Many medications
used to treat sepsis have unanticipated anticholinergic effects and high anticholinergic exposure has previously
been associated with delirium (a form of ABD) and mortality in other pediatric critical illness. Identification of
potential modifiable risk factors for ABD is imperative to target treatment strategies that can be implemented to
improve outcomes. We have assembled a diverse, experienced, and multi-disciplinary mentorship and
collaborative team that includes expertise in neurocritical care, long-term outcomes, neuropsychology,
pediatric sepsis, and biostatistics. This team will guide the candidate through a rigorous training plan involving
research conduct and career development training in neurocognitive domains and measurements, longitudinal
study design with optimization of follow-up, and advanced biostatistical methods. Finally, the candidate will
gain the necessary mentorship and training in clinical research and patient-centered outcomes to mature into
an independent clinician-scientist studying neurocognitive outcomes secondary to ABD during sepsis.

Public health relevance
PROJECT NARRATIVE Acute brain dysfunction occurs in 30% of the 100,000 children who have sepsis in the United States each year. In children, it is unknown if cognitive problems develop after sepsis and if these problems are related to acute brain dysfunction or other risk factors during sepsis. From this study, we will be able to determine how to identify new cognitive problems and how to potentially limit the development of these new cognitive problems in the first year after hospital discharge from sepsis.